Administrative Core

ADMINISTRATIVE/PROGRAM ENRICHMENT CORE
PROJECT SUMMARY
All activities of The Jackson Laboratory Nathan Shock Center (JAX NSC), including resource optimization,
quality control, fiscal management, outreach and compliance with institutional, NIH and NIH policies requires
effective management and oversight. The overall goal of the JAX NSC Administrative/Program Enrichment Core
is to provide effective Center administration and enhance the utility of JAX NSC resources throughout the aging
community. In the current funding period, the Administrative Core worked closely with its External Advisory Board
(EAB) to address challenges faced by the JAX NSC, including improving dissemination of data resources,
recruiting dedicated and accomplished faculty, and enhancing and optimizing phenotyping protocols in our
comprehensive cross-sectional and longitudinal mouse studies. In the coming renewal period, we will build on
our current success by providing the research community with even greater access to data, material resources
and collaborative opportunities. To achieve these goals, the Administrative/Programs Enrichment Core will carry
out the following specific aims: Aim 1: Support JAX NSC management and resource coordination through
an effective and experienced administrative structure, weekly staff meeting, quarterly Aging Interest Group
meetings, more efficient tracking and management systems for mouse resources, and resourceful leveraging of
JAX institutional support; Aim 2: Support JAX NSC External Advisory Board by incorporating improvements
recommended by an EAB consisting of leaders in the aging field; Aim 3: Enhance NSC visibility nationally by
maintaining and strengthening integration with other NSCs and the NSC Coordinating Center via outreach
efforts that include organizing courses and symposia and establishing a strong web presence; and Aim 4:
Organize and participate in joint conferences with other NSCs. Through the Administrative/Program
Enrichment Core, the JAX NSC will continue to support a robust, effective scientific and administrative structure
that complements that of the larger JAX institutional structure and, importantly, the overall goals of the NSC
program. The three principal investigators who constitute the central administrative structure have worked closely
for many years to successfully manage the JAX NSC and will continue to do so. The Core will coordinate the
activities of all other cores, streamline resource development and dissemination, centralize and grow the forward-
thinking aging program at JAX, offer time-honored and new courses and symposia highlighting aging research,
and support advanced genetic research in aging using novel mouse models. These activities are critical to the
Center's success and effectiveness in meeting its goals and the goals of the national Nathan Shock Program.